Neuromuscular Junction Dysfunction in Hyperkalemic Periodic Paralysis

Project Summary / Abstract
Career Development Context: This proposal presents a five-year research and career development
program focused on advanced, intracellular, electrophysiological training to improve the care of patients with
neuromuscular disease. The candidate (Adam Deardorff) is an early career MD/PhD trained clinician-scientist
with board certification in neurology and additional fellowship training with board eligibility in neuromuscular
medicine. He is junior faculty at the Wright State University Boonshoft School of Medicine with appointments in
the Department of Neuroscience, Cell Biology, and Physiology and the Department of Neurology. Under the
expert guidance of his primary mentor (Dr. Mark Rich) and scientific advisory committee, the outlined proposal
builds upon the candidate’s previous research and clinical expertise by integrating new training in translational
neuromuscular physiology with clinically relevant and rapidly translatable hypothesis testing. At the completion
of the funding period, he will have the necessary skills to undertake the physiologic analysis of every aspect of
the motor unit / segmental motor system, generate his own highly effective research programs, and collaborate
with other investigators around the world to advance patient care. The proposed experiments, training activities,
and mentorship are therefore vital to his long-term career goal of improving the lives of patients with
neuromuscular disease.
Research Context: Hyperkalemic Periodic Paralysis (HPP) is a rare genetic disorder due to a mutation
affecting muscle sodium channels. Patients experience episodic attacks of paralysis lasting minutes to days
when their blood potassium levels increase (by diet or exercise, for example). Afflicted individuals also
experience significant long-term sequelae, including progressive muscle weakness, muscle pain, and fatigue.
Unfortunately, there are few effective treatments for HPP outside of lifestyle modification. This proposal strongly
suggests that a) the primary mechanism of weakness in HPP has been missed and b) it is caused by reversible
failure of the neuromuscular junction (NMJ) rather than muscle fiber hypoexcitability (as has been previously
thought). Therefore, the experiments in this proposal will for the first time provide a highly detailed and systematic
investigation of muscle hypoexcitability (Aim 1) and the novel consideration of NMJ failure (Aim 2) in HPP.
Establishing reversible NMJ failure as an important cause of weakness will dramatically advance our mechanistic
understanding of HPP disease pathogenesis and suggest novel mechanisms of treatment with therapeutics
already FDA-approved to correct NMJ failure in other illnesses. After the K08 grant period, the candidate will
submit grant applications to test these novel therapeutic interventions and, if successful, rapidly translate the
findings into a clinical trial. Moreover, the findings would suggest NMJ dysfunction may be more common than
previously thought and could lead to new therapies in other muscle diseases as well.

Public health relevance
Project Narrative Establishing reversible NMJ failure as an important driver of weakness in HPP dramatically advances our mechanistic understanding of disease pathogenesis, which allows us to potentially correct NMJ failure with therapeutics already FDA approved for other illness. If we confirm our findings, we can submit additional grant applications to test novel therapeutic interventions using drugs already FDA approved to reverse NMJ dysfunction in other diseases and, if successful, rapidly translate these findings into a clinical trial for patients with HPP. Moreover, our findings suggest NMJ dysfunction may be more common in muscle disease than previously thought, and the techniques developed and used in this project may lead to development of therapy for weakness in other muscle diseases.